NIH Aplysia Renewal Year 29 - 33

The proposed diversity supplement will fund a two-year postdoctoral fellowship for
Dr. Javier Rodriguez Casariego within the National Resource for Aplysia supervised
by co-mentors Drs. Michael Schmale and Danielle McDonald. Appropriate plans are in
place to support educational and career development objectives of the candidate as
well as to provide training in the responsible conduct of research. The proposed
research program will continue experiments that explore how sub-lethal exposure to
hypoxia can modulate future responses to stress and the molecular mechanisms
involved in this type of memory, primarily through epigenetic mechanisms. Aims of the
project include the characterization of DNA methylation and non-coding RNAs in
hypoxia resistant and sensitive phenotypes, identify epigenetic markers supporting the
transgenerational inheritance of resistance, and the role of these mechanisms
regulating gene expression programs in the nervous system of Aplysia. This project is
consistent with the aims of the parent grant by expanding the use of Aplysia as a model
for health-related research in areas like neuroprotection to stroke and other
neurodegenerative diseases, and contributing to the development of an
ischemia/reperfusion injury model in this species.

Public health relevance
Aplysia are highly resistant to levels of hypoxia that would be lethal to humans or most other animals. The proposed program will fund a fellowship for a minority postdoctoral fellow to study how a particular type of cellular memory contributes to this ability and how this might inform mechanisms to increase the resistance of human brain cells to hypoxia.